In Vivo Knee Motion and ACL Biomechanics During Dynamic Activities

Abstract: Radiographic evidence of OA is present in more than 50% of patients 10 years after ACL
reconstruction. However, the etiology of early onset OA after ACL reconstruction is not well understood. While
previous work has demonstrated changes in joint motion following reconstruction, it is unclear how these altered
motions relate to changes in the local mechanical response of cartilage to in vivo loading. This information may
be critical to understanding the onset of OA, as the mechanical response of cartilage affects cartilage
homeostasis. In line with this mechanism, our pilot data indicates that regions of high cartilage strain measured
in patients with ACL injury and reconstruction are susceptible to decreased cartilage thickness, a characteristic
feature of OA. Importantly, these degenerative changes are observed as early as 18 months post-reconstruction.
Therefore, in this proposal our overall hypothesis is that site-specific changes in the mechanical response
of cartilage to loading following ACL injury and reconstruction are predictive of long-term cartilage
degeneration. Specifically, we hypothesize that in regions of cartilage experiencing elevated strain during
loading, early degeneration will be reflected by altered composition and decreased cartilage thickness. Thus, we
will measure localized cartilage strain, composition, and thickness at four time-points: after ACL injury but prior
to reconstruction, as well as at 3 months, 1 year, and 2 years after surgery. At each time point, a combination of
high-speed biplanar radiography and MR imaging will be used to measure local cartilage strains during in vivo
loading. To assess cartilage degeneration, we will use MRI to measure site-specific changes in composition
(using T1rho and T2 relaxation times) and cartilage thickness. Additionally, our analyses will account for relevant
biological variables such as age, sex, and BMI, and clinical factors such as graft placement characteristics and
meniscus injuries. In addition to mechanical factors, biological factors such as joint inflammation and lubrication
may also play a role in cartilage degeneration after ACL reconstruction. Therefore, synovial fluid and serum will
be collected to measure inflammatory mediators and metabolic biomarkers. Using this data, we will develop a
predictive model of cartilage degeneration after ACL reconstruction that utilizes both mechanical and biological
factors, as well as other demographic and clinical characteristics, to predict declines in cartilage health.
Furthermore, this comprehensive dataset will be used to develop clinical phenotypes to identify those at high
risk for cartilage degradation after ACL reconstruction. Importantly, the development of these phenotypes will
enable targeted treatment approaches focusing on surgical procedures, pharmaceutical targets, and non-
pharmacological interventions such as physical therapy or weight loss in preventing cartilage degeneration.
Therefore, our findings will both elucidate the role of alterations in the local mechanical response of cartilage on
degeneration after ACL reconstruction and improve the identification and treatment of patients at high risk for
cartilage degeneration.

Public health relevance
Project Narrative Early onset osteoarthritis (OA) is a major concern after ACL reconstruction. This project will develop a predictive model of cartilage degeneration after ACL reconstruction using a novel combination of mechanical factors, biological factors, demographics, and clinical characteristics. This information is critical to developing new targets aimed at OA prevention after ACL reconstruction.